Neural Control of Choroidal Function

PROJECT SUMMARY
In primates, including humans, the macula and especially the fovea, is critical for high-acuity vision. The
metabolic needs of the fovea and macula are primarily met by the choriocapillaris, the capillary network of the
choroid located immediately behind Bruch’s membrane. There is considerable evidence that compromised
choroidal perfusion contributes to many eye diseases, such as age-related macular degeneration and diabetic
retinopathy, that affect these retinal regions. Importantly, choroidal blood flow is substantially controlled by
inputs from the parasympathetic nervous system. However, the parasympathetic circuitry controlling the
choroidal vasculature in primates is very poorly understood. The precise locations of the pre- and
postganglionic parasympathetic motoneurons supplying the choroid, as well as their premotor inputs have not
been established, nor have the functional roles of these neurons been fully defined. Therefore, the overall goal
of this proposal is to determine the location and function of the parasympathetic circuits controlling the
choroidal vasculature in non-human primates. We propose to perform neuroanatomical, electrophysiological,
and pharmacological experiments to address these questions. Specifically, in Aim 1, we will use retrograde
tracers, both conventional and trans-synaptic, to identify the motor and premotor circuitry controlling the
parasympathetic innervation of the choroid. In the functional part of the study, we will use infrared (IR) laser
doppler flowmetry, IR laser speckle flowgraphy (LSFG), and optical coherence tomography (OCT)/OCT
angiography (OCTA) to measure the choroidal vasculature. Specifically, in Aim 2, we will study the effects on
the choroidal vasculature of modulating preganglionic motoneuron activity by electrical microstimulation and of
modulating retinal activity by light. In Aim 3A, we hypothesize that pharmacological inactivation of
preganglionic motoneurons reduces overall choroidal blood flow and thickness in darkness, reduces choroidal
blood flow compensation for changes in blood pressure, and eliminates luminance induced changes in the
choroidal vasculature. In Aim 3B, we hypothesize that electrolytic or chemical lesions of preganglionic
motoneurons will result in reduced choroidal blood flow. In the long term, we hypothesize that the retina will
show evidence of outer segment loss and inflammatory markers. We will non-invasively assess retina, retinal
pigment epithelium, and choroid health in life by OCT/OCTA, LSFG, and electroretinogram (ERG)/multifocal
ERG. We will further assess retinal health postmortem by retinal histology. The proposed experiments will
constitute the first extensive and systematic investigation of the circuitry and role of the parasympathetic,
preganglionic neurons controlling blood flow in the choroidal vasculature of a primate. These results will set the
stage for future studies in which this circuitry is modulated in order to improve the survival of central vision in
human macular degeneration.

Public health relevance
PROJECT NARRATIVE In primates, including humans, the central retina, especially the fovea, relies on the choroidal blood supply for metabolic and thermoregulatory support, but we know very little about the neuroanatomy or function of the autonomic pathways controlling primate choroidal blood flow. The proposed experiments constitute the first extensive and systematic investigation of the anatomy and physiology of the neural circuitry controlling the parasympathetic pathways supplying the choroidal vasculature of a primate. These results will set the stage for future studies in which this circuitry is modulated in order to improve the survival of central vision in models of macular degeneration.